GENOME-WIDE GENOTYPING OF EXISTING SAMPLES FROM ASIAN AMERICAN AND PACIFIC ISLANDER PARTICIPANTS IN THE CALIFORNIA TEACHERS STUDY COHORT

GENOME-WIDE GENOTYPING OF EXISTING SAMPLES FROM ASIAN AMERICAN AND PACIFIC ISLANDER PARTICIPANTS IN THE CALIFORNIA TEACHERS STUDY COHORT